Digital Multiplexed Analysis of Circulating Nucleic Acids in Small-Volume Blood Specimens

Abstract
Our goal is to develop a technology platform to repeatedly measure cancer biomarkers from a few drops of blood
collected from cancer patients at home. Our team identified that blood exosomal microRNA-375 predicts time to
survival of patients with metastatic castrate resistant prostate cancer (mCRPC). We succeeded in measuring
microRNA-375 in small volume blood samples collected by mCRPC patients at home, which we are now using
for longitudinal analysis of individual patients as they undergo treatment. This capacity to collect samples from
home has increased clinical value in the current era in which a pandemic necessitates decreased hospital visits
and encourages home-based care in oncology. However due to the small sample volume, it is not currently
possible to measure a panel of related biomarkers which are needed to address the broad genetic spectrum of
mCRPC, including genetic changes that drive therapy-induced clonal selection. Further, we have determined
that additional normalization standards are needed to improve validation and reproducibility. Therefore, our goal
is to perform high-dimensional multiplexing of well-characterized nucleic acid sequences from these home-
collected blood samples using a new assay called single-molecule flow (SiM-Flow). SiM-Flow allows rapid digital
counting of nucleic acids that have been extended and fluorescently labeled using a fluorescence-based flow
cytometer. We propose to develop and optimize instrumentation and barcoding technologies for quantification
of 20 distinct nucleic acid biomarkers that have been shown to be prognostic or predictive of therapy response
in mCRPC in addition to 10 normalization sequences, using samples isolated from home-collected fingerstick
blood specimens from patients. In particular, we will develop (1) a microfluidic single-molecule counting
instrument that evaluates femtoliter volumetric partitions with 5-color readout, (2) 5-color fluorescent labels based
on compact, brightness-equalized quantum dots optimized for dispersion profiles of optical prisms and spectral
sensitivities of silicon photomultiplier arrays, and (3) nucleic acid coding schemes for diverse exosomal
microRNA and mRNA targets. We will validate agreement between this new multiplexed digital assay and digital
droplet PCR, optimize normalization probes, and correlate patient survival with the biomarker panel and
measurements from at-home samples. Our team has broad expertise needed to accomplish this work, including
specialists in molecular probes and single-molecule fluorescence (Andrew Smith), prospective clinical trials and
mCRPC biomarker discovery (Manish Kohli), microfluidic devices with optical integration for blood analysis
(Rashid Bashir), and clinical biostatistics (Jonathan Chipman). Success in this project will have the potentially
transformative technological outcome of an instrument and assay for rapid, longitudinal evaluation of numerous
circulating cancer biomarkers in individual patients using biospecimens that are readily collected at home. This
platform could fill a void in clinical oncology by reporting molecular changes occurring in metastases in response
to therapies, which may be used to match and finely tune treatments to individual patient response profiles.

Public health relevance
Narrative The goal of this project is to develop a new technology platform to measure tens to potentially hundreds of different cancer biomarkers from a single fingerstick of blood collected by patients at home as they begin a new treatment. Our team succeeded in quantifying two distinct nucleic acid targets in such specimens for patients beginning treatment for metastatic castrate resistant prostate cancer. A substantial increase in the number of targets is now needed to validate measurements and to address the diverse genetic landscape of the disease, and could enable the prediction of drug response so that treatment regimens can be rapidly and finely tuned to enhance efficacy and increase survival.